MECHANISM OF ETHNIC DIFFERENCES IN PSYCHOTROPHIC RESPONSES

To compare the response and explore potential reasons for differences in response to psychotropic medication in different ethnic groups. The factors hypothesized in determining response are: inherited differences in drug metabolizing liver enzyme systems, protein binding, and dietary influences. To evaluate subjects from African-American, Asian, Caucasian and Hispanic backgrounds with extensive physical and laboratory examinatins. The investigatin will be composed of two parts: pharmacogenetics & protein binding and dietary influences.